Aligning PCPs and Patients with Alzheimer's Research Efforts: MyAlliance for Cognitive Health

Abstract
New models for recruiting research participants are required to support current and future trials.
Recruiting adequately diverse samples of research participants is among the biggest challenges slowing
research efforts to treat and prevent Alzheimer's disease (AD). Study populations often fall short in
representing the genetic, ethnic, racial, and socioeconomic diversity necessary to generalize trial results while
the speed of recruitment into trials directly impacts the cost and time to complete studies. These issues are
only worsening as the number and size of current and planned trials have dramatically expanded.
The University of Kansas Alzheimer's Disease Center (KU ADC; P30AG035982) created MyAlliance for
Cognitive Health (MyAlliance) to accelerate participation in research and emphasize reaching under-
represented groups (URG: predominantly African Americans, Latinos, and rural residents). The Kansas City
region and the state of Kansas are increasingly diverse (>20% minority). MyAlliance is a sustainable and
reproducible strategy for engaging a diverse population through 1) a PCP Network to improve dementia care
through a financially-sustainable Chronic Care Management program, 2) a Patient Network (MyAlliance
Research Registry, derived from patients in the PCP network), and 3) a Community Network of diverse
stakeholders delivering robust outreach and education.
The sustaining value of MyAlliance is its clinical mission to improve care for all patients and families
dealing with dementia. MyAlliance will support PCPs in community practice – emphasizing practices serving a
high proportion of URG – with social work Navigators to deliver Chronic Care Management services for their
dementia patients. This clinical value is the engine to ensure consistent PCP engagement over time and
sustain the network to create a permanent recruitment infrastructure in the community.
This R24 award will result in new approaches, content, and tools that will be portable to the AD Center
network and beyond to enhance national research recruitment efforts and work to change the culture of
research recruitment in the community by linking, aligning, and engaging PCPs, patients, and community
stakeholders with research efforts.

Public health relevance
Project Narrative: Recruiting adequate numbers of research participants with diverse backgrounds is among the biggest challenges slowing research efforts to treat and prevent Alzheimer's disease (AD). The University of Kansas Alzheimer's Disease Center is accelerating diverse participation in research by linking, aligning, and engaging PCPs and their patients with research efforts. This R24 award will result in new approaches, content, and tools that will be portable to the AD Center network and beyond to enhance national research recruitment efforts, changing the culture of research recruitment in the community.